Developing climate cohorts to understand health associations and resilience and susceptibility factors in Ghana

Project summary
Global health gains achieved over the past half century are at risk of being eroded by climate change, which
disproportionately affects low- and middle-income countries (LMICs). In LMICs, scientific and policy planning
capacity to incorporate climate compatible strategies into climate sensitive areas like the health sector is
severely hampered by the lack of empirically derived estimates of local climate sensitivities from their countries
and, critical for policy, an understanding of population-specific resilience and susceptibility factors. Indeed,
recent climate sensitivities relied on data from LMICs with large scale administrative data (Brazil, China) as a
proxy for the African continent. Despite this major limitation, these data suggest that the effect of temperature
on mortality in susceptible groups will be ~50% larger in regions for which there is no available data, such as
Africa. We propose to build climate science expertise in Ghana by mentored research and the development of
two reinforcing sets of “climate cohorts.” We will leverage the well-characterized, extant Ghana Randomized
Air Pollution and Health Study to examine associations between climatic exposures on maternal-child health.
We will also begin work with the Kintampo Health and Demographic Surveillance System (KHDSS) to prepare
for future climate work leveraging this rich data resource. This work will begin to refine climate health sensitivity
estimates, provide key insights into resilience and susceptibility factors, and fill urgently-needed policy and
practice-relevant evidence gaps. A long-term goal of this project is to provide a framework for continued
climate science in Ghana and a model for other African countries with similar extant cohorts, to collectively
catalyze climate research on the African continent.

Public health relevance
Project Narrative The proposed activities will position the KHDSS and GRAPHS cohorts as a significant resource for expanding our understanding of the health sensitivities of climate in low- and middle-income country communities. In the long-term, this work will build a pipeline of climate scientists in Ghana and a platform that will inform cost- effective policies and public health interventions to promote health in the face of a changing climate.